Healthy People 2020 (HDS) Heart Disease and Stroke

To provide support, for a multiyear project to support the National Health Interview Survey (NHIS) to develop measures to assess progress toward achieving Healthy People 2020 Heart Attack, Blood Pressure, and Cholesterol objectives.